BRAIN Integrated Resource for Human Anatomy and Intracranial Neurophysiology

PROJECT SUMMARY/ABSTRACT
Intracranial recordings in patients undergoing neurosurgical interventions provide a unique opportunity to directly
access, study, and learn about both normal human brain function and neuropsychiatric disease. Because of their
value, the NIH has made significant investments in this line of research through the BRAIN Initiative and has
likewise required public archiving of data through the Data Archive for the BRAIN Initiative (DABI). With the
accumulation of data from over 500 subjects, DABI presents a unique opportunity to conduct large scale studies
using data from multiple sites and investigations. Moreover, with the inclusion of both neurophysiological and
imaging data (including anatomic and connectivity-based imaging), DABI has the potential to address important
questions about functional-anatomic relationships in human neurophysiology and sources of variability across
age, disease, and anatomy. There is a strong emerging yet underexplored literature that neural oscillation
patterns relate to brain morphometry, yet the tools to explore this with greater spatial precision and spectral
sensitivity are currently unavailable. While the multimodal nature of DABI data has the potential to significantly
impact such questions, the data is not currently in a form that makes it easily accessible or analyzable. The
BRAIN integrated Resource for human Anatomy and Intracranial Neurophysiology, B(RAIN)2, has an overall aim
of creating a spatially integrated and standardized dataset that will enable such large scale studies. In Aim 1,
we will (1) identify and curate data for inclusion in B(RAIN)2 based on required data elements (as well as solicit
additional archiving from BRAIN funded investigators), (2) perform standardized neurophysiological signal
processing and anatomic localization, (3) perform standard anatomic image processing, based on the Human
Connectome Project framework and established quality control measures, and (4) transform all data into a
standard space for large scale analyses. To ensure high impact and continued growth of B(RAIN)2, in Aim 2, we
will share, document, and define pipelines for continued data integration, including webinars and training
modules and providing support to potential users. Finally, in Aim 3, we will conduct a demonstration project to
highlight the power of B(RAIN)2, investigating the relationships between motor cortical beta power and peak
frequency as a function of cortical thickness, connectivity, and disease. The proposed work will enable
investigators to harness the power of intracranial physiology and neuroimaging collected across BRAIN-funded
sites to increase the power and impact of these valuable and relatively rare signals. Future investigators will use
the B(RAIN)2 standardized metrics across anatomy and physiology in both native and standard space to perform
novel analyses and gain unique insights into anatomic contributions to variability in human neural oscillator
signals.

Public health relevance
PROJECT NARRATIVE Despite significant advances in human neurosciences emerging from direct intracranial recordings of brain activity in human volunteers, it can be difficult to fully interpret these signals because of an incomplete understanding of the factors that affect their quality and patterns. This is further complicated by the relative rarity of these signals which make it challenging to conduct the large scale studies that are needed to study the factors that may contribute to signal variability, such as underlying brain anatomy. In this project, we use the power of numbers derived from the Data Archive for the BRAIN Initiative which hosts data from over 535 subjects from 24 institutions to create a large integrated multimodal dataset to enable large scale analyses of these brain signals and their significance, especially as it pertains to the influence of brain anatomy on these neural signals.